Development of Strategies for the Synthesis of Heterocycles

Project Summary/Abstract
Heterocycles are ubiquitous components of pharmaceutical drugs essential for human
health. A particularly attractive approach to nitrogen containing heterocycles is the
modification of cheap and readily available amines via C–H bond functionalization.
However, methods that efficiently accomplish this task typically require the use of
expensive transition metal catalysts and/or oxidants. This proposal is focused on the
design and development of efficient and practical methods for amine functionalization,
including the development of asymmetric variants. The main goal is the alpha-
functionalization of amines through conceptually new and underdeveloped methods of
substrate activation. Unique methods for the synthesis of heterocycles will also be
explored in the context of asymmetric Lewis and BrØnsted acid catalysis. In addition to
targeting the rapid preparation of compounds related to structures with known biological
activities, efforts will center on the development of particularly powerful reactions that
rapidly produce new polycyclic heterocycles. A priority is the generation of new
structural frameworks that are absent from current drug discovery screening libraries.

Public health relevance
Project Narrative PUBLIC HEALTH RELEVANCE: As the majority of pharmaceutical drugs contain heterocycles, often in the form of azacycles, the ability to prepare these materials in the most rapid way possible is of the utmost importance. The broad availability of drugs is directly dependent on the existence of cost-efficient methods that can reliably build complex molecular structures. The main objective of this proposal is the development of powerful new methods and strategies for the synthesis of heterocycles, employing C–H bond functionalization and other techniques that will facilitate rapid access to valuable building blocks for the synthesis of biologically active compounds and pharmaceuticals.